CORE--METHODOLOGY

DESCRIPTION (Provided by the applicant): The Methodology Core, in collaboration with the Administrative Core, will provide the following services: (1) Survey organization and management; (2) Survey research methodology; (3) Data collection; (4) Sampling design -- (a) sample size and power calculations, (b) sample selection; (5) Development and pre-testing of questionnaires; (6) Data management; (7) Statistical analysis; (8) Tracking of sampled families.